Engineering the fetal environment for in utero treatment of spina bifida bone defect

ABSTRACT
Spina bifida (SB) is the most common congenital cause of lifelong paralysis in the United States, and
approximately four children are born daily with this devastating disease. Myelomeningocele (MMC), the most
severe form of SB, results from the incomplete closure of the neural tube and absent overlying spine, resulting
in lifelong paralysis, bowel and bladder dysfunction, musculoskeletal deformities, and cognitive disabilities. In
utero surgical repair improves morbidity, but functional recovery is incomplete, and most children are still unable
to walk independently. We developed a treatment for MMC that augments the in utero surgical repair with
placental mesenchymal stem cells (PMSCs) and found that in utero treatment with PMSCs prevents hindlimb
paralysis at birth in the fetal sheep MMC model via a neuroprotection mechanism. However, treated lambs
developed severe kyphosis, causing spinal cord compression and decreased motor function long-term due to a
lack of spinal bone support. Therefore, regenerating the bony vertebrae defect is critical in protecting the newly
repaired spinal cord and maintaining long-term motor function. It is well known that the dynamic regenerative
milieu in the womb naturally supports the generation of fetal tissues by endogenous stem cells. Therefore,
leveraging the abundant endogenous cells in the fetal environment presents a unique opportunity for tissue
regeneration in utero. The behavior of endogenous cells during bone development in the fetal environment is
highly dependent on several critical and complementary factors, such as integrins and extracellular vesicles
(EVs). Given that exogenous morphogenetic factors are contra-indicated for fetal and pediatric uses by the FDA,
recruiting and guiding endogenous stem cells through engineered materials with integrin ligands and EVs
represents an innovative, safe, and effective approach to drive the assembly of appropriate cells and form
functional bony tissues in the developing fetus. Using one-bead one-compound (OBOC) combinatorial
technology, we identified specific integrin ligands, LLP2A and LXW7, with a high affinity for integrins α4β1 and
αvβ3, respectively, that are highly expressed on MSCs and endothelial progenitor cells (EPCs)/endothelial cells
(ECs), and that are critical for recruiting endogenous MSCs and EPCs/ECs to the bone defect site. We also
demonstrated placental MSCs-derived EVs (PMSC-EVs) possess strong osteogenic and angiogenic potentials.
In this study, we propose to develop a collagen-based scaffold modified with LLP2A/LXW7 and PMSC-EVs to
synergistically recruit and guide endogenous stem cells for vascularized bone regeneration in utero. We will
evaluate the regenerative functions of this product using our well-established fetal sheep spinal bone defect and
fetal sheep MMC models. This fetal tissue engineering approach provides a transformative solution for
regenerating the bony structural defect in MMC patients. Once established, this solution could combine with our
previous neuroprotective approach, significantly improving the care for MMC patients and lowering healthcare
costs. This technology can also have wider implications in treating other congenital skeletal defects.

Public health relevance
PROJECT NARRATIVE Myelomeningocele (MMC), the most severe form of spina bifida (SB), is the most common congenital cause of lifelong paralysis, which results from the incomplete closure of the neural tube and absent overlying spine during fetal development. Fetal surgery offers great benefits to the repair of MMC, but the lack of vertebral dorsal arches over the MMC defect remains present throughout life, as bone never redevelops over the spinal cord neuronal defect. In this study, we aim to develop an “smart”, safe, and bio-inductive bioengineered scaffold that can recruit and guide endogenous cells in the fetal environment to regenerate the missing vertebral arches before the baby is born.